Super-Resolution Imaging of Alzheimer's Disease Hyperphosphorylated Tau Aggregates

Project Summary
Alzheimer’s disease (AD) is a neurological disorder characterized by the accumulation of microtubule-
associated protein tau into many abnormal intraneuronal aggregates detected at distinct brain regions. Their
emergence strongly correlates with the progressive severity of AD diagnosed patients’ clinical symptoms and
neuropathological features. These observations suggest tau aggregation plays a crucial and toxic role in AD.
Tau is a monomeric highly soluble protein that maintains the assembly and stability of microtubules. Tau’s
function is regulated through post-translational modifications (PTMs) of a specific number of residues, primarily
phosphorylation. Previous studies indicate that the tau proteins that make up polymorphous insoluble tau
aggregates (e.g., neurofibrillary tangles) have abnormal hyperphosphorylation. Based on these observations, it
is suggested that ubiquitous hyperphosphorylation of tau promotes its aggregation in disease. However, the
precise link between the pattern and degree of tau hyperphosphorylation with aggregation is unclear.
Furthermore, how a heavily molecularly modified protein can form a wide range of morphologically diverse
aggregates within one disease is not well-understood. These questions have not been investigated thoroughly
due to the diffraction limit of conventional light microscopy (~250nm), in which aggregates of a size well below
this limit are not resolvable. By labeling human postmortem AD brain tissues with multiple hyperphosphorylation-
specific phosphor-tau antibodies and super-resolution imaging, I have been able to identify tau oligomers ( 20-
30 nm), linear fibrils (30-250 nm), branched fibrils (50-350 nm), and NFTs (>1μm). Based on this preliminary
data, I hypothesize that the tau oligomers/small fibrils present in AD have unique PTM profiles that arise from
the combination of tau proteins hyperphosphorylated at different residues. I also hypothesize that
morphologically distinct insoluble tau aggregates in AD have unique PTM profiles and that these profiles match
the PTM profiles of tau oligomers/small fibrils. To test these hypotheses, the aims established in this proposal
will determine the relative frequency of tau proteins carrying a particular array of hyperphosphorylated sites
within tau oligomers, fibrils, and NFTs. I will achieve this by combinatorial immunostaining with established
phosphor-tau antibodies, multicolor super-resolution imaging, and advanced quantitative analysis using machine
learning to rigorously evaluate the hyperphosphorylation profiles of all tau aggregates present in human AD
tissues. These studies will demonstrate that it is possible to determine the PTM profiles of tau oligomers and
morphologically distinct insoluble tau aggregates in human AD tissue. Furthermore, these research strategies
will open the door to compare tau oligomer PTM heterogeneity across several tauopathies, including Cortical
basal degeneration and Pick’s disease. Furthermore, the research strategies developed herein can be applied
to study the PTM profiles of other aggregation-prone proteins, including α-synuclein, huntingtin, and others.

Public health relevance
Project Narrative The insoluble tau aggregates present in multiple neurological disorders such as Alzheimer’s disease are morphologically and molecularly heterogeneous species that emerge from the assembly of tau seeds carrying specific molecular profiles. I aim to illustrate that tau’s molecular modifications in the form of its degree and pattern of hyperphosphorylation vary within tau oligomers and morphologically distinct insoluble tau aggregates in Alzheimer’s. These studies will facilitate the development of therapies that can accurately target various tau aggregates through the identification of the specific molecular signatures of tau seeds and tau aggregates present in human pathology.